Clinical Health Services and Research Core

CLINICAL AND HEALTH SERVICES RESEARCH CORE
Abstract
The Clinical and Health Services Research (CHSR) Core promotes multidisciplinary intervention research in
diverse clinical settings that mitigates the impact of mental health disorders, substance use, and other HIV
comorbidities and advances the uptake and efficacy of pre-exposure prophylaxis (PrEP) and treatment as
prevention (TasP) approaches. The CHSR Core will foster linkages and research collaborations that integrate
clinical and social/behavioral approaches, and contribute expertise in HIV comorbidities research in clinical
settings. Over the next five years, the Core will promote and support high quality research in areas in which
psychological factors, mental health and treatment for substance use disorders within health systems are of
utmost importance. Areas of special emphasis will include: engaging youth who are either HIV-infected or at
risk for HIV, including transgender youth; and optimizing health care for those with substance use disorders
and/or mental health comorbidities, and for women experiencing interpersonal violence and/or involved in the
correctional system. As part of CIRA's New England HIV Implementation Science Network, the CHSR Core will
emphasize development and support of research on linkage, retention and other implementation gaps in the
treatment cascade, and issues particularly salient to HIV care in small clinics and health systems. The CHSR
Core will also lead CIRA's international research development efforts, promoting and supporting strategic
international collaborations with potential to have a high impact on the epidemic occurring in high prevalence
areas. Through joint meetings with the Community Research and Implementation Core, CHSR will promote
and support research addressing gaps across the continuum of care that entail both community-based and
health care system approaches. Dr. David Fiellin, Professor of Medicine and Public Health, will serve as CHSR
Core Director. Dr. Fiellin has conducted extensive research on substance use and mental health and has
expertise in IS. Dini Harsono, MSc will serve as the Core Assistant Director. Other senior investigators in the
Core have substantial research experience related to the interface between primary care, HIV, addiction and
mental health comorbidities, and bring both research and clinical backgrounds in nursing, pediatrics, addiction
medicine, geriatrics, and psychiatry and expertise with diverse populations such as veterans, people who use
drugs and alcohol, youth, elderly, gay/bisexual men and others. These include: Dr. Brian Forsyth, Professor of
Pediatrics who will lead the CHSR Core's international research program and facilitate a new Youth Work
Group; Dr. Paul Cleary, Professor of Public Health and Director of CIRA, an expert in health services research;
Dr. Frederick Altice, Professor of Medicine, who conducts implementation research focused on diverse risk
groups both domestically and internationally; Dr. Gerald Friedland, Professor of Medicine, recognized
internationally for his extensive research relating to HIV care and its comorbidities; Dr. Ann Kurth, Dean of the
School of Nursing who provides leadership in international research on the continuum of care; and others.